Regulation of neutrophil plasticity, heterogenicity, and functional ambivalency by WNT5 in colitis

Project Summary / Abstract:
Neutrophils are the most abundant leukocytes in the circulation. They are the first to be
recruited to the sites of inflammation and abundantly present in many inflammatory diseases.
Neutrophils are important for host defense against microbial infections, but also responsible for
tissue injuries during acute and chronic inflammation responses. Thus, they are generally
considered as being detrimental to tissue well-being in sterile inflammation-related diseases
such as acute lung injury and myocardial, renal, and cerebral ischemia-reperfusion injuries as
well as some of the autoimmune diseases (inflammatory bowel disease and Type I diabetes).
Neutrophils possess great plasticity, heterogenicity, and functional ambivalency. They can be
beneficial or detrimental to host well-being depending on contexts. In our investigation of
WNT5A and WNT5B, we found that the lack of these proteins protected colitis as the result of
increased suppression of colon cytotoxic CD8 T cells by CD101-high neutrophils. These CD101
high neutrophils are produced from splenic extramedullar hematopoiesis, which is stimulated by
WNT5-deficiency. In this application, we plan to examine the role of CD101 in immune
suppression, characterize functional responses of CD101-high neutrophils, investigate the
mechanisms for WNT5 to regulate splenic EMH, and determine the transcription factors that
control molecular and hyper-immunosuppressive characteristics of CD101H neutrophils.

Public health relevance
Project Narrative: Neutrophils are the most abundant leukocytes in the circulation and involved in many human inflammation-related diseases. We here propose to investigate how different sub-types of neutrophils are produced and function using a colon inflammation model. Our work will produce potential therapeutic targets and agents to treat human diseases in which neutrophils are involved.